Project 2: Isolation Chemistry of Cultured Cyanobacteria

PROJECT SUMMARY – PROJECT 2
The overarching goal of this Program Project Grant renewal application is to discover natural products that can
serve as anticancer drug leads from diverse natural sources. Project 2, located at the College of Pharmacy,
University of Illinois at Chicago (UIC), is comprised of microbial, chemical and biological elements. The primary
goals for Project 2 are the discovery of new lead anticancer compounds from cyanobacteria. The underlying
hypothesis for Project 2 is that the diverse natural product structures from cultured non-marine
cyanobacteria will be a rich source for anticancer leads. To achieve the stated goals the Specific Aims for
Project 2 are as follows: 1) to obtain, culture, extract, and prepare fractions of cyanobacterial strains, and
to sequence the genome of selected strains. We will obtain 100 cyanobacterial strains per year. The strain
collection will focus on samples collected in the Upper Midwest and Great Lakes regions of the U.S. Each strain
will be cultured, extracted, fractionated, and provided for biological evaluation in the biological test systems
available at Core 1 (UIC) and Project 1 (OSU) and Project 3 (UNCG). 2) To isolate and determine the
structures of active cyanobacterial metabolites, and to improve yields of lead compounds. Extracts
showing promising activity will be fractionated using activity-monitored fractionation to obtain pure natural
product(s). The structurally characterized, active isolates will be extensively evaluated in the biological test
systems available to the program. We will re-isolate larger amounts of any candidate compound. To improve
yields, when necessary, we will evaluate different cultivation conditions. 3) To explore biosynthetic potential
of our cyanobacterial library. Our cyanobacterial strain library currently contains close to 1500 isolates and
represents one of the largest collections in the U.S. As a complementary and integrated approach aimed at
increasing the structural diversity of our compound library, we will sequence the genomes of ~100 strains. Strains
will be selected for sequencing based on promising biological activity and/or taxonomic diversity. For a subset
of strains (~10), we will also attempt to activate potentially silent pathways by cultivating the strains under
different culture conditions. The various interactions and information exchanges envisioned among the
components of this Program Project will greatly enhance our chances of achieving our collective goal of finding
useful, naturally occurring cancer chemotherapeutic leads.

Public health relevance
PROJECT NARRATIVE – PROJECT 2 The primary purpose of Project 2 of this Program Project is to discover new cancer chemotherapeutic leads from cyanobacteria. The proposed research will impact human health by creating new lead compounds for the development of drugs to treat cancer. Some of the compounds discovered may work by new mechanisms of action, thus increasing our understanding of how to treat this disease.